2016 U.S. Fire Service Technology Summit

? DESCRIPTION (provided by applicant): The National Fallen Firefighters Foundation (NFFF) seeks to sponsor a 2-day conference in San Jose, California in August 2016 to examine the current state of the art of fire service technology, and uncover existing gaps in its use to increase firefighter health and safety. The proposed 2016 U.S. Fire Service Technology Summit is the second in a series of meetings that support Firefighter Life Safety Initiative #8 utilize available technology wherever it can produce higher levels of health and safety. Modeled after the consensus process proven successful in earlier occupational health projects, this Summit will foster collaborative involvement between the fire service and both current and potential players in the field of fire service research. Approximately 75 individuals will be invited, includng representatives of fire service constituency organizations with authority to articulate their interests and positions. Additional attendees, including fire chiefs, operations chiefs, and information technology directors will represent fire departments. Researchers will be charged with making presentations on both existing technologies and those in development, and facilitating breakout sessions devoted to consensus development of 1) recommendations for future technology research; 2) a pathway for fire service stakeholder input from project inception to adoption; 3) methods to inform, educate and train firefighters in existing technologies; 4) mechanisms for the technology industry to collaborate with the fire service in the transfer of emerging technologies to fire service use; and 5) identification of potential diverse funding opportunities to meet the identified technological needs of the fire service. Silicon Valley was strategically chosen as the location for this conference in order to tap in on local resources for creativity and innovation, and to build upon the culture of the area. As a result, this meeting wil initiate a strategic partnership between this nation's greatest loci of tech development and the fire service, which needs this support to save both civilian and firefighter lives.

Public health relevance
PUBLIC HEALTH RELEVANCE: Approximately 100 firefighters die each year in the line of duty. These deaths can be attributed to cardiac events, vehicular accidents, burns, smoke inhalation, structural collapse, and myriad other causes. In addition, 80,000 firefighters are injured each year, and there is an increasing body of evidence pointing to a relationship between cancers and toxin exposure by firefighters. The human cost of loss of life is immeasurable, and the economic cost of a firefighter fatality or early retirement due to injury or illness is enormous. Over the past decade, considerable research has led to a more comprehensive understanding of the ability of technology to increase levels of health and safety within the fire service. Technological solutions are emerging to reduce the risks of many of the major causes of firefighter disease and injury. While fire service science is moving forward, huge gaps exist in terms of operationalizing the newest technologies. This conference will address technology in four areas 1) fire operations 2) fire prevention 3) training 4) communications, will bring together researchers, representatives of fire service constituency organizations, and chiefs from a broad spectrum of departments/agencies to hear the state-of-the-science, and find ways to improve the research to practice pipeline within the industry. Consensus development will focus on identifying 1) recommendations for future technology research; 2) a pathway for fire service stakeholder input from project inception to adoption; 3) methods to inform, educate and train firefighters in existing technologies; 4) mechanisms for the technology industry to collaborate with the fire service in the transfer of emerging technologies to fire service use; and 5) identification of potential diverse funding opportunities to meet the identified technological needs of the fire service. Clearly this is a unique opportunity to identif ways to address risk through the use of technology for this occupational group, and will ultimately lead to a safer, healthier fire service and improved public safety.